Putting Implementation into context to advance the management of mechanically ventilated patients.

PROJECT SUMMARY
Over one million Americans undergo invasive mechanical ventilation (IMV) annually in intensive care units
(ICUs). A few interventions have improved patient-centered outcomes in IMV patients, including sedation
minimization, corticosteroid administration in selected patients, and low tidal volume ventilation and prone
positioning in the subgroup patients with acute respiratory distress syndrome (ARDS). However, variability
exists across ICUs in processes of care, clinical outcomes, and resource utilization. ICUs are highly complex
interprofessional environments, and knowledge gaps remain regarding how contextual elements influence
implementation determinants in different ICUs. The coronavirus disease 2019 (COVID-19) pandemic created
unprecedented surges of patients requiring IMV and catalyzed rapid and dynamic changes in critical care
delivery, facilitating some evidence-based practices after many years of persistently low penetration, and
impeding others. Furthermore, new evidence, such as corticosteroids for COVID-19 and pneumonia, may have
later influenced practice changes for IMV patients more broadly. Thus, this major disruption in critical care
delivery is a unique opportunity to gain new knowledge about implementation in the ICU context.
The overall objective of this proposal is to better understand the interplay between contextual factors and
intervention features in care delivery for IMV patients. Guided by implementation frameworks, we will employ
state-of-the-art causal inference methods and innovative qualitative approaches to conduct three specific aims:
(1) Quantify penetration of four evidence-based treatments – sedation minimization, corticosteroid
administration, low tidal volume ventilation, and prone positioning – over time among IMV patients and specific
subgroups; (2) Develop a novel conceptual model of ICU implementation incorporating relationships between
determinants and contextual elements; and (3) Apply implementation mapping to create adaptable menus to
facilitate evidence-based practices. We will apply state-of-the-art causal inference methods to analyze a
diverse, multicenter retrospective cohort of IMV patients admitted to more than 30 ICUs in 16 hospitals before,
during, and after the height of the COVID-19 pandemic. In addition, we will use cutting-edge qualitative
techniques and implementation research frameworks and will engage an array of stakeholders to develop
implementation menus for each treatment that not only provide strategies to promote utilization of evidence-
based treatments but also guidance for tailoring those strategies to different contexts. This project will advance
the science of care delivery in a high-stakes setting by increasing the evidence regarding how contextual
elements interact with treatment characteristics in critical care delivery. It will generate direct preliminary data
for future implementation studies to test strategies to promote evidence-based care of IMV patients. Finally, it
will create a conceptual model with potential application to delivery of critical care interventions in different ICU
contexts more broadly.

Public health relevance
PROJECT NARRATIVE A few interventions have been shown to improve outcomes in patients who undergo invasive mechanical ventilation; however, ICUs vary in delivery of these treatments and patient outcomes. ICUs are highly complex interprofessional environments, and knowledge gaps exist regarding how differences in ICU environments influence care delivery. The overall objective of this proposal is to better understand the interplay between ICU contextual factors and characteristics of different treatments in order to optimize care delivery for a vulnerable population at high risk for morbidity and mortality.